Effects of Social Networks and Policy Context on Health among Older Sexual and Gender Minorities in the US South

PROJECT SUMMARY
No changes being proposed.

Public health relevance
NARRATIVE No changes being proposed.